Integrative Cardiovascular Pathophysiology

Summary/Abstract
This renewal application requests support for pre- and post-doctoral trainees in an Integrated
Cardiovascular Pathophysiology (ICVP) training program. Faculty mentors in the ICVP training
program primarily have their appointments within the Cardiovascular Research Center (Directed
by Dr. Steven Houser, ICVP program director) or the Center for Translational Medicine (directed
by Dr. Walter Koch, Co-Director of the ICVP program) at Temple University School of Medicine.
The purpose of our program is to provide a broad based multidisciplinary training experience for
pre-doctoral fellows, post-doctoral fellows and summer medical students in the area of
integrative cardiovascular pathophysiology (ICVP). ICVP faculty members reside with many
different basic science and clinical Departments, but their research laboratories are largely
within the CVRC and CTM which are housed on two adjacent floors of a new medical research
building. ICVP investigators/mentors have related interests in fundamental properties of the
cardiovascular system and the aberrant changes in these properties that cause cardiovascular
dysfunction in diseases including ischemic heart disease, hypertensive heart disease,
atherosclerosis, ischemic vascular disease, metabolic syndrome and diabetic cardiovascular
diseases. Graduate students and post-doctoral fellows will receive didactic training in human
physiology and pathophysiology, complemented by advanced training in cellular and molecular
biology and the appropriate use of animal models of human cardiovascular disease. Graduate
student and fellow research projects will have basic and translational components. The students
and fellows will be expected to investigate problems that go beyond a single molecule and
address questions within the context of cardiovascular disease models. Portions of these
projects will be performed in the laboratories of different investigators, ensuring that students
and fellows are exposed to varied scientific approaches. All trainees will be involved in activities
to enhance their grant and manuscript writing and oral communication skills. Group mentoring
by junior and senior faculty will ensure trainees are well qualified to assume positions as leading
investigators able to rapidly translate new knowledge into new therapies or targets for therapies.
A variety of recruiting strategies will be used to attract a diverse group of trainees that reflect the
diversity of our country. The goal is to train a diverse group of new Ph.Ds. and post-doctoral
fellows that are able to fill a national need for the next generation of biomedical scientists who
can develop therapies for cardiovascular diseases..

Public health relevance
Narrative The goal is to train Ph.D. students and post-doctoral fellows to fulfill the need for new investigators to discover mechanisms of human disease.